Nonpharmacological Treatment Effects on Proinflammatory Biomarkers among Youth with Chronic Sickle Cell Pain

PROJECT SUMMARY
Chronic pain in pediatric sickle cell disease (SCD) is a major clinical challenge due to the complex interaction
of biological, psychological, and social factors. Consequently, current pharmacological and non-
pharmacological treatments have variable and limited effectiveness resulting in the persistence of chronic pain
during adolescence into adulthood. Optimal treatment of chronic SCD pain requires an individualized,
interdisciplinary care approach that targets the multifaceted biopsychosocial factors that maintain chronic pain,
such as chronic inflammation, nervous system sensitization, stress, and emotional distress. The objective of
the proposed research is to determine if there are measurable elevated proinflammatory biomarkers among
youth with chronic SCD pain that are driven by stress, depression, and anxiety that can be targeted and
modified through non-pharmacological treatment approaches, such as cognitive-behavioral therapy. The aims
of the proposed study are to 1) determine if there are key inflammatory biomarkers associated with chronic
SCD pain and stress, and 2) determine if inflammatory biomarkers change for youth with chronic SCD pain
following an adaptive, family-focused, culturally-informed cognitive-behavioral intervention termed Back2Life
that is tailored to address the unique needs of chronic pain in pediatric SCD. A 24-month retrospective
longitudinal study will evaluate stored blood samples from youth with chronic SCD pain to determine the rates
of elevated proinflammatory cytokines and their relationship to pain and stress. We will prospectively evaluate
the trajectory of proinflammatory biomarkers among youth with chronic SCD pain participating in a proof-of-
concept clinical trial of Back2Life to see if these markers change with treatment and inform preliminary effect
sizes in order to prepare for a larger clinical trial. Our long-term goal is to develop novel comprehensive
treatment approaches to treat chronic pain in pediatric SCD and improve quality of life.

Public health relevance
PROJECT NARRATIVE Chronic pain significantly diminishes all aspects of quality of life among children and adolescents with sickle cell disease (SCD), yet there are limited effective treatments available to date. This research will begin to identify key proinflammatory biomarkers associated with chronic SCD pain that can be targeted and modified through non-pharmacological treatment approaches, such as cognitive-behavioral therapy. The long-term goal of this research is to identify objective inflammatory biomarkers as a biological response to an adaptive cognitive-behavioral intervention (termed Back2Life) that is tailored to meet the unique needs of youth with chronic SCD pain and their family.